Modulation of ferroptotic cell death by mitochondrial calcium signaling

Project Summary/Abstract
Ferroptosis is a unique type of programmed cell death that is induced by excessive lipid peroxidation.
Emerging evidence suggests that ferroptosis represents a vulnerability in certain types of cancer that have
acquired resistance to therapies. However, the signaling mechanisms that can be harnessed to promote
cancer cell ferroptosis and its functional consequence on the tumor microenvironment (TME) reprogramming
are poorly understood. In this Proposal, we aim to study a previously unrecognized anti-ferroptotic effect
imparted by mitochondrial calcium signaling, which may also contribute to the establishment of
immunosuppressive TME. Mitochondrial calcium uniporter (MCU) is a highly selective calcium channel that is
localized to the inner mitochondrial membrane, which promotes the production of metabolite acetyl-coenzyme
A (acetyl-CoA) by targeting the pyruvate dehydrogenase (PDH). In preliminary studies, we discovered that
MCU-mediated acetyl-CoA generation blocks both cancer cell ferroptosis and antitumor immunity. We found
that genetic ablation of Mcu (Mcu−/−) abolished acetylation of the glutathione peroxidase 4 (GPX4), a critical
gatekeeper of ferroptosis, which correlated with impaired GPX4 activity and enhanced sensitivity to ferroptosis
induction. Moreover, Mcu deficiency in cancer cells significantly blunted their growth and improved antitumor
immune response. Therefore, blockade of MCU function may represent a promising therapeutic regimen for
cancer. The goal of our proposed research proposal is to examine the function and mechanism of MCU-
mediated acetyl-CoA metabolism on GPX4-controlled ferroptosis and its impact on antitumor immunity. We
hypothesize that 1) decreased acetyl-CoA production in the absence of MCU sensitizes cancer cells to
ferroptosis due to GPX4 hypoacetylation; 2) elevated ferroptotic cell death of Mcu−/− cancer cells promotes the
production of type 1 interferon by intratumoral myeloid cells via the cyclic GMP-AMP synthase (cGAS)-
dependent DNA-sensing pathway, leading to enhanced antitumor immunity; and 3) pharmacological inhibition
of MCU by MCU-i11 synergizes with programmed death-1 (PD-1) blockade in limiting tumor growth.
Representative syngeneic tumor models with high or low immunogenicity will be employed to examine the
effect of MCU-mediated ferroptosis on antitumor immunity. Single-cell RNA sequencing analysis of tumor-
infiltrating immune cells in response to MCU-i11 treatment will be performed to understand whether MCU
inhibition promotes antitumor immunity. Results of these studies will provide novel insights into the induction
and function of ferroptosis in rejuvenating antitumor immunity, which can potentially lead to the identification of
new therapeutic targets in cancer treatment.

Public health relevance
Project Narrative Ferroptosis represents a vulnerability in certain cancers with acquired resistance to therapies. Based on my preliminary results, I aim to study the role and mechanism of mitochondrial calcium signaling-mediated acetyl coenzyme A metabolism in the regulation of ferroptotic cell death and antitumor immunity. Understanding the consequence of cancer cell ferroptosis affecting tumor microenvironment will be instrumental for the generation of new therapeutic approaches for cancer treatment.